PHASE II STUDY OF VIROLOGIC AND IMMUNOLOGIC EFFECTS OF ZDV AND D4T

This study will evaluate the eficacy of monotherpy versus combination antiretroviral therapy in patients with CD4 counts between 300 and 600/mm3 and no prior antiretroviral experience and to compare the relative virologic efficacy of d4T alone or in combination with ZDV in the absence or presence of ZDV experience.